Effects of alcohol on sleep/activity rhythms: Focus on Hypocretin/Orexin

PROJECT SUMMARY/ABSTRACT
Clinical studies have demonstrated that drinking typically begins in adolescence and may lead to alcohol
use disorders (AUD). Both younger and older adults with heavy drinking/AUDs are twice as likely to have
insomnia that can last for several years. Yet the complex interactions between sleep, drinking, and
maintenance of sobriety remain poorly understood despite their profound clinical implications. We postulate
that cycles of binge drinking and withdrawal can lead to hyper-arousal states that disrupt sleep and may further
drive drinking. One barrier to progress in testing this hypothesis has been the lack of translatable animal
models that would allow the control necessary to investigate the long-term effects of alcohol on sleep and
daytime functioning. Studies from our laboratory, in rats, have demonstrated that moderate ethanol exposure,
either in adolescence or in adulthood, can produce long-term changes in the sleep/wake EEG that mirror the
human condition, as well as an enhancement of drinking in adulthood. Alcohol studies in human subjects have
recently focused not only on nighttime polysomnographic findings but also on daytime sleepiness and
disrupted activity levels, as measured by “fit bit” devices. We propose to further test a “fit bit” system that we
have developed in rats to monitor alcohol-induced sleep/wake disturbance, as well as use it to assess the
efficacy of potential therapeutic interventions, and to test mechanistic physiological hypotheses related to the
etiology of alcohol-induced disturbances of sleep and functional wakefulness. A prominent role of the
hypothalamic peptide hypocretin/ orexin (Hct/OX) in homeostatic control of both the sleep/wake cycle and
ethanol-seeking and drinking behaviors has been demonstrated. We have also shown partial pharmacological
reversal of alcohol-induced sleep pathology by Hct/OX antagonists, however, we do not know if they also
impact drinking. New pharmacological studies will test the specificity of the Hct/OX1 vs. Hct/OX2 receptor, vs.
dual receptor antagonism, to modify sleep vs. drinking following alcohol. We have also demonstrated that
alcohol exposure increases hypothalamic Hct/OX, and RNA-seq/ ATAC-seq studies show that the Hct/OX2
receptor gene is impacted in frontal cortex. The new mechanistic studies we propose will focus on the
hypothalamic Hct/OX system using siRNA-mediated hypocretin/ orexin OX1 and OX2 knockdown, gene
expression using RNA-seq, and epigenetic changes using ATAC-seq. Such studies could also inform
precision/personalized medicine decisions by adding evidenced-based data to the suggestion that Hct/OX1
antagonists could be used for individuals with AUD with enhanced craving and Hct/OX2 antagonists for those
with more profound sleep disturbances, and dual receptor antagonists for those with both.

Public health relevance
PROJECT NARRATIVE This project tests the hypothesis that, in the rat, exposure to alcohol during adolescence induces long-term changes in sleep and activity rhythms, increases in drinking, that are in part mediated by hypocretin/Orexin system in key sleep circuits. These studies also test new therapeutics for adolescent alcohol-induced sleep/wake pathology.